Developmental Research Program

DEVELOPMENTAL RESEARCH PROGRAM: SUMMARY
The DRP is an essential component of the Brain SPORE, providing yearly support to 3-4 projects that have
translational potential. Funding is flexible, supporting projects for a period of two years or less. It is expected
that DRP investigators will develop their pilots sufficiently to either replace main projects that have reached
conclusion, or are not progressing. If there is no such need, DRP project investigators will be encouraged to
secure independent funding, such a through the R01 mechanism. The DRP will be maintained for the entire
project period; SPORE funds will be matched by Institutional support.
In collaboration with the Northwestern's
Brain Tumor Institute at the Lurie Cancer Center, there will be a highly structured process for solicitation,
review and evaluation of pilot projects; women and minority investigators will be strongly encouraged to apply.
The specific aims of the DRP are:
Aim 1. To solicit, identify and support meritorious translational research projects that are considered as having
a high probability of impacting the diagnosis and/or treatment and/or prevention of brain tumors.
Aim 2. To facilitate developmental project maturation into full SPORE projects or independently funded
projects.
Aim 3. To attract outstanding new and experienced investigators currently not working on brain tumors to
pursue brain tumor research, with a special emphasis on supporting women and minority investigators.

Public health relevance
DEVELOPMENTAL RESEARCH PROGRAM: NARRATIVE The Developmental Research Program (DRP) of the Northwestern Brain Tumor SPORE provides yearly funding to 3-4 projects that have promising translational potential. DRP projects that experience outstanding development may replace main projects that are not progressing, or the associated project investigators will be encouraged to secure independent funding in brain cancer research. !